Fit2ThriveMIND: Optimizing a mHealth Physical Activity Intervention with Mindful Awareness Lessons in Breast Cancer Survivors

PROJECT SUMMARY/ABSTRACT
There are approximately 4 million breast cancer survivors (BCS) in the U.S., and this population is expected to
increase by 1 million in the next ten years. Increased moderate-to-vigorous intensity physical activity (MVPA) is
consistently associated with reductions in treatment-related side effects, cancer recurrence and mortality, and
increased QOL in BCS. Yet, the majority of BCS (~70%) do not meet MVPA recommendations (i.e., 150
mins/week). Existing studies of MVPA in BCS are largely resource-intensive, costly, and deliver multiple
components (i.e., coaching calls, supervised exercise) simultaneously limiting scalability. Three evidence-
based strategies have been identified that may be particularly useful for overcoming these barriers and
increasing MVPA in BCS: 1) electronic delivery of a MVPA program, 2) social support, and 3) mindfulness
training. However, little is known about the unique roles of social support and mindfulness in MVPA promotion.
More granular information about the discrete effects of these components is needed to optimize intervention
configuration in order to maximize an effective and scalable MVPA program for BCS. The purpose of this study
is to apply the Multiphase Optimization Strategy (MOST), to determine which types of social support and
mindfulness training intervention components optimally increase and maintain MVPA in a 6-month mHealth
MVPA intervention with a 6-month follow-up. MOST is a framework adapted from engineering that uses highly
efficient factorial experiments to evaluate individual, and combined, effects of intervention components to
determine which ones can be reduced, eliminated, or replaced to improve efficiency. Inactive BCS (n=304) will
receive a core intervention consisting of the FIt2ThriveMIND app and Fitbit and be randomly assigned to four
components under consideration for inclusion in the optimized intervention: 1) general mindfulness training; 2)
MVPA-specific mindfulness training; 3) text-coaching; and 4) engagement of a buddy. We will also examine the
effects of increasing MVPA on symptom burden, other intensity activities (i.e. light and sedentary), and sleep
quality and duration and potential mediators and moderators of component effects. All components with have a
6-month duration except text coaching which will include “boosters” personalized to an individual's MVPA goal-
attainment during the 6-month follow-up period. The proposed study represents the first systematic effort to
use MOST to design an optimized, scalable mHealth MVPA intervention in BCS that incorporates mindfulness
and specifically tests a maintenance strategy. Knowledge gained from this study will inform the development of
more effective and scalable interventions to improve health and disease outcomes among BCS. This study will
lead to an improved understanding of how to effectively change and maintain BCS' MVPA and inform the
development of more effective and scalable interventions to improve health and disease outcomes among
BCS.

Public health relevance
PROJECT NARRATIVE The public health significance of this study lies in its potential to develop an improved understanding of how to effectively change breast cancer survivors' physical activity behavior. These findings could result in more effective, scalable physical activity interventions for this population, and ultimately, improve health outcomes and reduce healthcare costs associated with cancer recurrence, comorbidities, and premature death in breast cancer survivors.